Gene therapy for disorders of the extracellular matrix

PROJECT SUMMARY
COL4A1 and COL4A2 mutations cause Gould syndrome (GS) – a multisystem disorder for which clinically
heterogeneous cerebrovascular disease is the major consequence. Cerebrovascular disease in individuals with
GS can range from porencephaly caused by germinal matrix hemorrhages in utero, to infantile seizures, to age-
related cerebral small vessel disease (cSVD) and vascular cognitive impairment and dementia (VCID). Hallmarks
of cSVD observed in individuals with GS include subcortical microbleeds, enlarged perivascular spaces, and
lacunar infarcts. Importantly, Col4a1 mutant mice faithfully model patient phenotypes. Moreover, Col4a1 mutant
mice have age-related cerebrovascular dysfunction including loss of myogenic tone and impaired hyperemic
responses that are thought to be critical to VCID progression.
The extracellular insults resulting from COL4A1 and COL4A2 are heterogeneous and complex, which represents
a significant barrier to mechanism-based interventions. However, because GS is a devastating monogenic
disease with a defined genetic cause, it is an ideal candidate for correction of the root cause of the disease via
genome editing technologies. In this proposal, we will leverage vastly improved CRISPR nucleases, base editors,
and prime editors along with novel viral vectors to test therapeutic approaches using primary GS patient cells
and mouse models of GS. This project will provide important pre-clinical data to develop the first genome editing-
based therapy for this severe monogenic disorder. The successful completion of this work could eventually
provide a one-time, lifelong treatment that prevents both childhood stroke and age-related VCID for GS patients
and create a roadmap for correction of similar diseases.

Public health relevance
PROJECT NARRATIVE Gould syndrome – caused by mutations in type IV collagen alpha 1 (COL4A1) and alpha 2 (COL4A2) – is a multisystem disorder critically involving the cerebral vasculature and for which there are no interventions. The mechanisms by which mutations lead to disease are complex and poorly understood representing a barrier to development of mechanism-based interventions. However, because it is a devastating, dominant disorder, Gould syndrome is an ideal candidate for correction via genome editing technologies. This study will provide the pre- clinical data needed to develop personalized treatments for patients with Gould syndrome and other extracellular matrix disorders.